GENETIC STUDIES OF CAMPYLOBACTER RECTUS

Campylobacter rectus is a Gram negative, motile, anaerobic, rod-shaped bacterium frequently isloted from adult periodontitis lesions. One potential C. rectus virulence factor is a toxin which kills human polymorphonuclear leukocytes and monocytes. Previously, we cloned a region from C. rectus that reacted with two probes generated from the N-terminal sequences of the 104 kDa toxin and with an A. actinomycetemcomitans leukotoxin probe. In an expression vector, the 6 kb insert expressed a 60 kDa protein reactive with polychonal antibody to the 104 Kda protein. In view of the truncated nature of this protein, we developed a C. rectus phage library. Whole genomic DNA from C. rectus was partially digested with the restriction endonuclease Sau 3A and ligated in Bam HI site of lambda GEM-12 vector. The library was screened with labeled insert from the positive clone and with the anti-toxin antibody resulting in three positive clones. Sequence analysis of the plasmid clone indicated significant sequence similarity between the cloned C. rectus toxin and other cytokysins including the Escherichia coli hly gene (48.9%), Pasteurella haemolytica 1tx gene (47.7%), and the A. actinomycetemcomitans 1tx gene (42.5%). Based on our sequence data we conclude that the C. rectus toxin may be closely related to the A. actinomycetemcomitans leukotoxin and similarly may have an important role in the pathogenesis of certain forms of periodontal disease. Key Words: C. rectus, Toxin, Periodontitis